Hemodynamically induced molecules regulating the initiation of intracranial aneurysms

Project Summary Ruptured intracranial aneurysms (IAs) are the main cause of non-traumatic subarachnoid
hemorrhage, the most severe form of stroke. Discovering ways to prevent IAs from forming could dramatically
impact patients’ lives, but understanding of why and how IAs form is limited. This proposal aims to identify
molecular signals that initiate IAs by examining arterial gene expression during IA formation.
Hemodynamics play a crucial role in IAs. Arteries respond to changes in blood flow by remodeling to keep
fluid shear stress at baseline levels without loss of vessel strength and integrity. But in IAs, remodeling thins and
weakens the arterial wall. It is hypothesized that IAs form when flow induces endothelial cells in the intima to
produce signals that cause maladaptive responses in the media. In a proof-of concept study, the investigators
used RNAseq of microdissected cerebral arteries in rabbits to observe gene expression in the intima under
aneurysm-inducing flow, and in the contiguous media where dystrophic remodeling occurs. The results
demonstrated that this approach can reveal potential regulators of IA formation by identifying intimal genes that
are uniquely expressed in nascent IAs and whose expression correlates with destructive medial responses.
A comprehensive screen is proposed for genes that control dystrophic remodeling during IA formation. This
will be done using a rabbit model, in which ligation of the carotid arteries increases flow in the posterior
circulation, causing constructive enlargement of the basilar artery while an IA forms at the basilar terminus. Gene
expression will be measured by RNAseq in intima and media that are laser microdissected from the basilar artery
and terminus, and transcriptomes from ligated and unligated rabbits will be compared to identify flow-induced
changes. Changes at the basilar terminus will be compared with the basilar artery to reveal genes that are unique
to dystrophic IA remodeling. Correlation analysis will then be performed on intimal and medial gene pairs to
detect potential signal-response relationships.
Preliminary studies suggest that BMP2 is one such signal for IA formation. To test this, rabbits will be treated
with JL5, an inhibitor of BMP2-receptor activity, while IAs are induced by carotid ligation. Tissues will be assessed
for (a) expression of medial genes that are characteristic of aneurysmal remodeling, using RNAseq, and (b)
initiation of aneurysmal damage, as determined histologically. It is predicted that disrupting the BMP2 signaling
pathway will prevent dystrophic responses in the media and inhibit flow-induced IA-initiating damage.
This project will identify regulatory pathways acting specifically during pathological remodeling that leads to
IAs. In addition, it will provide unprecedented characterization of gene expression during trophic and dystrophic
arterial remodeling. Understanding the molecular mechanisms behind vascular responses to flow will inform
strategies for prevention and treatment of pathological remodeling events, and could ultimately lead to
pharmacological interventions for clinical mitigation of IAs.

Public health relevance
Project Narrative When brain aneurysms rupture, they cause the most severe form of stroke. This project seeks to understand why and how brain aneurysms form by examining the genes that are expressed in arteries when they are forming brain aneurysms in rabbits, a system which mimics many aspects of human aneurysm formation. Understanding the changes in gene expression that cause an aneurysm to develop will inform strategies for preventing and treating aneurysms, and could ultimately lead to pharmacological or lifestyle interventions for mitigating brain aneurysms in humans.